Case Comprehensive Cancer Center Support Grant

OVERALL
PROJECT SUMMARY/ABSTRACT
The mission of Case Comprehensive Cancer Center (Case CCC), now in its 27th grant year, is to promote a
coordinated, translational research-oriented culture of scientific discovery applied to human cancers, that
improves cancer detection, prevention, treatment, cure, and survivorship in Cleveland, Northeast Ohio and
around the world, and to disseminate its advances to patients and populations. The Center provides leadership
and oversight of collaboration for basic cancer research oriented toward identification of novel therapeutic
targets; prevention, control and population research; therapeutic and non-therapeutic clinical research across
the disease spectrum; and community outreach. These accomplishments include examples of practice
changing impact within the catchment area and nationally. The Center coordinates all aspects of cancer
research in Cleveland and Northern Ohio, including activities of the affiliate institutions of Case Western
Reserve University, Cleveland Clinic, and University Hospitals. The Center provides opportunities to participate
in clinical trials to almost 16,000 cancer patients (over 62% of cancer cases in the catchment area) who are
newly diagnosed annually in the region. The Case CCC is organized around 7 Research Programs, 13 Shared
Resources, and a clinical and behavioral cancer research infrastructure that prioritizes innovative translational
research and investigator-initiated clinical trials that cut across the Research Programs. The Case CCC
includes 279 members (172 Full, 32 Associate, and 75 Clinical) from 7 schools and 68 academic departments
who actively participate in Center activities including Program and Shared Resource meetings and retreats,
and leadership committees, each promoting a transdisciplinary approach that facilitates discovery and clinical
application. The cancer focus of the Center is exceptional, with over $77M in direct funding and over $26M in
direct NCI funding. Institutional commitment is also exceptional, codified through an updated Memorandum of
Understanding. The consortium members will provide over $128M of internal funds for cancer research in the
next grant cycle. The Case CCC and its affiliate institutions have established an outstanding infrastructure that
enables its members to improve the prevention, diagnosis, and treatment of cancer through discovery,
implementation and dissemination, and collaborative transdisciplinary research while providing state-of-the-art
care and treatment to cancer patients and their families. The Case CCC yields tangible benefits as an active
partner with the NCI by supporting cancer relevant scientific research with direct benefit to patients and the
general public.

Public health relevance
OVERALL PROJECT NARRATIVE The Case Comprehensive Cancer Center is Northeast Ohio’s only NCI designated comprehensive cancer center providing bench-to-bedside medical research involving partnerships between basic, clinical and population scientists to speed translation of laboratory discoveries into new prevention/intervention and cancer treatments.